2021 Chronobiology Gordon Research Conference and Gordon Research Seminar

We request partial support for the 22nd Chronobiology Gordon Research Conference (GRC) and the accompanying 5th Gordon Research Seminar (GRS), which will be held Bates College in Lewiston, Maine from June 20-25th, 2021. Any funds that we receive from the NIH will be used to support registration fees and/or travel costs for half the speakers/session chairs at GRC and GRS with a particular focus on supporting the younger researchers, postdoctoral fellows and graduate students. The GRC/GRS meetings on Chronobiology have a rich history of attracting a wide-range of researchers working at many different levels with diverse methodologies and model organisms. The GRS will focus on training and mentorship, while the GRC will present the latest unpublished work from both senior and emerging stars of the field. The sub-theme for the 2021 Chronobiology meeting is 'Inputs, circadian oscillators and outputs: From single cells to human health' to emphasize the study of diverse organisms and the application of these insights in the clinic and workplace, achieved with molecular, cellular, physiological and behavioral approaches. In metazoans, the master circadian clock is in the brain, and chronic circadian disruption by modern lifestyles has important implications for human behavior, metabolism and healthy aging, so the conference fits well within the mission of the NINDS. Speakers and discussion leaders represent senior established figures and younger emerging stars of the field and have been selected by consulting with an informal committee consisting of mid-career and junior figures in the field. We are enriched for female speakers/session chairs with several underrepresented minorities as well as representation from a range of nationalities, from the Americas, Europe and Far East to promote cultural, racial and gender diversity. Apart from mentorship activities, the GRS will feature 10 trainee speakers, one of whom will be promoted to give a short talk at the GRC along with 9 other younger scientists selected from abstracts, providing a useful learning experience for the trainees and early career scientists.

Public health relevance
Circadian rhythms coordinate the timing of behavior and physiology in most eukaryotes and some bacteria, synchronizing life with Earth's day/night cycle. Changes in work schedules and lighting environments over the past century have disrupted circadian clocks to disturb natural sleep-wake cycles and induce or exacerbate neurological, mental and metabolic disorders. The GRC/GRS Chronobiology meeting will bring together the world's leading experts and a diverse array of younger researchers to discuss recent advances from a wide array of organisms that incorporate approaches from theoretical to molecular, cellular, physiological, developmental and behavioral studies, all the way to translation of this research to the workplace and the clinic.